Study the Treg-IL-27 axis in immune regulation

Regulatory T (Treg) cells, a specialized immune population, are known for their role in maintaining
immunological tolerance. Mounting evidence has suggested that Treg cells not only come in “different
flavors” phenotypically and functionally and play distinct roles in different tissue microenvironments.
Consistent with these findings, our previous analysis of tissue Treg cell transcriptome profiling data has
revealed unexpectedly elevated expression of IL-27, specifically in gut-associated Treg cells isolated from
inflammatory settings. In humans, genome-wide association studies have identified IL-27 as a candidate
gene within a susceptibility locus for inflammatory bowel disorder (IBD). Significantly, less IL-27 was found in
people harboring the risk alleles relative to those with the nonrisk alleles. These studies provided evidence
linking IL-27 and IBD and suggested that the observed elevations in IL-27 in certain patients probably
represent an anti-inflammatory response, albeit insufficient to control the ongoing intestinal inflammation. In
this application, by using Treg cell-specific gene targeting approaches, our preliminary results have shown
that Treg cell-derived IL-27 is crucial to control Th17 immunity particularly in the intestinal tissue. Further
single-cell RNA sequencing (scRNA-seq) analysis has identified a CD83+CD62Llo Treg cell subset that is
distinct from previously characterized intestinal Treg cell populations as the main IL-27 producers.
Nevertheless, the molecular mechanisms and the environment factors that drive the expression of IL-27
specifically in gut Treg cells during inflammation remains poorly defined. Through employing molecular,
biochemical, and immunological approaches with whole animal experimentation, we will first examine the
Treg cell-intrinsic molecular mechanisms accounted for the induction of IL-27 in intestinal Treg cells
particularly under inflammatory conditions. Next, as intestine is a special tissue location colonized by over
100 trillion commensal microorganisms that have been shown to be crucial in modulating Treg cell biology
and T cell immunity, by employing cutting-edge microbiome technologies, as well as mice with microbiome
interventions, we will identify and functionally validate the potential microbes that contribute to the induction of
IL-27 in gut Treg cells. Accomplishing the aims proposed in this application will undoubtedly extend our
fundamental knowledge the Treg cell-IL-27 axis in maintaining intestinal homeostasis and provide further
insights into tissue specific-Treg cell-mediated immune regulation under different cellular and environmental
settings.

Public health relevance
By employing immunological and state-of-the-art molecular approaches, combined with cutting-edge microbiome technologies, as well as mice with genetic and/or microbiome interventions and novel single-cell, sequencing-based methods in studying IL-27-expressing Treg cells under both physiologic and pathologic conditions, the proposed research aims to explore the molecular and cellular mechanisms underlying the Treg cells/IL-27 axis in regulating intestinal tolerance and homeostasis. Accomplishing the aims proposed in this application will greatly extend our fundamental knowledge of tissue-specific Treg cell-mediated immune regulation and provide further insights into the development of new therapeutic means to treat human immune disorders.